Inclusive Excellence Training Program in the Systems Biology of Cardiovascular Inflammation

Project Summary
An outstanding, diverse group of 30 faculty mentors has joined efforts across multiple departments and schools
at the University of Minnesota (UMN) to form a new Ph.D. graduate training program entitled, "Inclusive
Excellence Training Program in the Systems Biology of Cardiovascular Inflammation." This program fills a major
void at our institution by focusing emphasis on the highly clinically relevant problem of inflammation in
cardiovascular biology, obesity, diabetes and metabolism with study focus from gene to whole organism. This
new predoctoral training proposal addresses a major mission of the NHLBI by focus on physiological systems
training of cardiovascular and metabolic inflammation, and this new program will position trainees for diverse
successful outcomes in the dynamically changing future workforce. This new training program will also fill a large
void in the predoctoral training grant landscape at the UMN. Faculty mentors come from several different colleges
and departments across campus, including Integrative Biology and Physiology (IBP), Biomedical Engineering,
Biochemistry, Cell Biology and Genetics, Microbiology and Immunology and clinical units in Medicine, including
Cardiology and Endocrinology and Metabolism, and Pediatrics. The unique focus and singular effort of this
proposal is directed at training the next generation of biomedical scholars in the principles and application of
Integrative and Systems Biology. In the purest sense, our focus is distilled into the mechanistic study of human
physiology. By any name, whether it be physiology, integrative biology, systems biology, functional genomics,
or other, this training grant’s premise is that understanding biological function from cells, to organs, to the whole
living organism, represents the leading wave of new knowledge discovery in biomedical science now and in the
decades to come. Graduates from this program will be well versed in quantitative approaches to biology and
capable of dissecting complex mechanistic pathways in the living animal. This proposal gains considerable
strength by aligning with outstanding UMN gateway graduate programs to markedly broaden and deepen the
applicant pool from which we will select outstanding trainee candidates. Moreover, the proposal includes unique
tailor-made academic courses in the Physiology of Inflammation and in Computational System Physiology
featuring state-of-the-art computational biological and informatics approaches. These courses have been
developed expressly for this new training program. Here Ph.D. trainees will gain insight into to the most urgent
problems today in human patients with metabolic and cardiovascular medical disorders. Trainees will gain further
experiential training in physiological research via conferences, seminars, symposia, retreats, journal clubs, and
group meetings with program faculty, including physician-scientists. This program is designed to enable our
graduates to pursue unique career pathways, spanning from academia to bio-industry in systems and integrative
biology fields of research.

Public health relevance
Project Narrative Inclusive Excellence Training Program in the Systems Biology of Cardiovascular Inflammation is a new training program at the University of Minnesota. This program fills a major void at our institution by focusing emphasis on the highly clinically relevant problem of inflammation in cardiovascular biology, obesity, diabetes and metabolism with study focus from gene to whole organism. This program will train the next generation of biomedical researchers by leveraging outstanding faculty with successful mentoring history and new core facilities for a stellar training program for our trainees.